NALOXONE EFFECT ON LUTEINIZING HORMONE SECRETION IN PREMENSTRUAL SYNDROME

Luteinizing hormone (LH) secretion is influence directly by endorphins. The protocol will test the hypothesis that patients with PMS have altered levels of B-endorphin during the luteal phase compared to the follicular phase. Serial LH levels will be measured in patients and controls during baseline and naloxone infusion periods on 5 selected days of the menstrual cycle.